NHLBI WORKSHOP/CONFERENCE SUPPORT

WHI-nuMoM2b Cohort Studies Workshop aims to increase the involvement of early career investigators in the NHLBI women’s health cohort studies. Selected scholars will receive hands-on mentoring from WHI and nuMoM2b investigators at this intensive 2-day workshop with the goal of having each scholar publish a manuscript using data from one (or both) cohort studies, and ideally maintain involvement as co-investigators.